Generating and Investigating Antigen-Deficient Islets in Autoimmune Diabetes

PROPOSAL SUMMARY
Hybrid Insulin Peptides (HIPs) are a new family of autoantigens in Type 1 Diabetes (T1D). These peptides
form through covalent fusion of pro-insulin fragments to other beta-cell peptides. HIPs contain non-genomic
amino acid sequences, making them plausible targets for autoreactive T cells. We demonstrated that HIP-
reactive CD4 T cells trigger diabetes in non-obese diabetic (NOD) mice, are present in residual islets of organ
donors with T1D, and can be detected at significantly elevated levels in the peripheral blood of recent-onset
T1D patients. We also verified the presence of HIPs in human and murine islets by mass spectrometry. Our
data indicate that the protease Cathepsin D is responsible for the generation of HIPs that are targeted by
diabetes-triggering CD4 T cell clones. Here we will generate NOD mice carrying a mutation that prevents the
generation of HIPs. We predict that HIP-deficient beta-cells of these mice cannot be recognized by pathogenic
CD4 T cells and the mice will be protected from disease onset. We will analyze the islets of these mice to
assess HIP-content and T cell infiltration. We will also study disease incidence in these mice and determine
whether pathogenic CD4 T cell clones can transfer disease into these mice. Beta-cells, deficient of disease-
critical autoantigens, could allow us to reverse autoimmune diabetes in NOD mice and humans without the
need for immune-modulation or shielding of beta-cells through encapsulation.

Public health relevance
PROJECT NARRATIVE Hybrid Insulin Peptides (HIPs) are a new family of antigens in autoimmune diabetes that are targeted by diabetes-triggering CD4 T cells in non-obese-diabetic (NOD) mice and by autoreactive T cells in residual islets of T1D donors and in peripheral blood of recent onset T1D patients. We identified cathepsin D (catD) as the primary enzyme responsible for the formation of HIPs in subcellular organelles of beta cells. Here we will study the role of HIPs as critical T cell epitopes in autoimmune diabetes through the generation of a NOD mouse carrying a mutation, which disables the formation of critical HIPs through the catD-mediated mechanism.